A Multiple Health Behavior Change Intervention for Overweight and Obese Smokers

Project Summary/Abstract
This K23 award provides the PI with mentored research career development training necessary to become an independent
researcher capable of developing and testing innovative interventions targeting problematic use of addictive substances
and other maladaptive patterns of behavior associated with obesity or other comorbidities. Overweight and obese smokers
are disproportionately at risk for disease, disability, and premature death but may be reluctant to give up smoking due to
the fear of subsequent weight gain and trouble managing their weight without cigarettes. Applying weight gain prevention
as part of a multiple health behavior change (MHBC) program prior to smoking cessation, can help overweight and obese
individuals lose weight and buffer against post-cessation weight gain. Achieving some degree of success with behavioral
weight loss may result in decreased negative affect, increased future-oriented decision-making, and increased self-efficacy
to manage weight and change smoking with great potential impact on subsequent smoking cessation outcomes. The K23
research developed this MHBC intervention for treatment-seeking overweight and obese smokers and used qualitative
focus group data (completed Year 1) and data from an open series of patients (completed Year 3) to refine treatment. In
Year 4, a small 2-group randomized controlled clinical trial (RCT) began aiming for 60 overweight or obese smokers
(BMI ≥ 25) to be assigned to either weight gain prevention (an intervention based on self-regulation approaches to
produce and maintain weight loss as a way to effectively prevent weight gain) or healthy lifestyle education (an attention-
placebo comparison condition matched for contact time) before smoking cessation treatment. Participants are randomized
to 8 weeks of weight gain prevention or lifestyle education followed by 8 weeks of cognitive behavioral therapy for
smoking cessation with combination nicotine replacement therapy. Smoking cessation counseling sessions include brief
maintenance information according to assigned condition. Intervention feasibility and acceptability are assessed and
preliminary data regarding efficacy of the intervention on weight and smoking outcomes will be analyzed. The PI works
with an experienced and knowledgeable team of mentors (Drs. Damaris Rohsenow, Rena Wing, Rosemarie Martin,
Suzanne Colby, and Jennifer Tidey) to continue to pursue training relevant to this proposal including: (1) conducting
randomized controlled trials for health behavior change interventions for smokers with comorbid conditions, with an
initial primary focus on obesity, (2) implementing the stage model of treatment development for clinical behavioral
therapy research including qualitative methodology for therapy development, (3) learning advanced statistical techniques
for analyzing longitudinal data in clinical trials, and (4) strengthening professional research career development skills.
Preliminary efficacy data obtained in the proposed study represents an important first step in creating an innovative,
empirically-supported, MHBC intervention with high significance to public health and will be used to pursue a fully-
powered R01 grant and transition to research independence. Supplemental research funds will provide continuity of
research by supporting research personnel to sustain progress on the RCT phase of the research during a period in which
the PI will experience a significant life event that would otherwise impact research progress and productivity.

Public health relevance
Project Narrative Smoking cigarettes, eating too much, and being physically inactive tend to occur together and lead to a much greater chance that a person will become ill and die prematurely. In this study, a new treatment is being developed and tested that targets changing multiple health behaviors such as diet, exercise, and smoking in overweight and obese individuals who smoke cigarettes. If we find that providing a weight gain prevention intervention prior to smoking cessation treatment helps smokers quit and reduces associated weight gain, this multiple health behavior change intervention could become the gold standard of treatment and greatly impact public health.